Developing a Comprehensive Food and Feed Program Rapid Response Team for Pennsylv

RRT Abstract A core mission of the Pennsylvania Department of Agriculture (PDA is to develop and maintain the ability to rapidly and efficiently respond to incidents that may adversely impact Pennsylvania's food and feed supply inventory. Pennsylvania provides food, fiber, and fuel to 12.5 million citizens and is represented by 60,000 post-harvest food facilities, and is valued at $46.4 billion. Food safety represents a public health and economic concern which must be managed to address today's natural and intentional food system threats. PDA has a mandate to continue to enhance the work done on the regulatory front while creating and growing collaborative efforts that bring agencies, non-governmental organizations, and private sector groups together to enhance the safety and security of the food supply. It is this mandate that drives PDA to improve and modernize existing food safety protocols and to be proactive on both food security and food safety. Under this pretense, PDA has implemented initiatives and programs to help strengthen the Pennsylvania food system. Some of these initiatives include food safety response objective-based strategies and procedures; intra and inter-agency communications; the Food Employee Certification Program; and, continued understanding of Emergency Support Function 11 response protocols which are primarily managed by PDA.

Public health relevance
Project Narrative One of the Pennsylvania Department of Agriculture's (PDA) core responsibilities is to protect public health by rapidly and efficiently responding to incidents that may adversely impact Pennsylvania's food and feed supply. On a daily basis, PDA inspects animal feed producers, agronomic products, eating and drinking establishments, food processing facilities, wholesale facilities, summer feeding programs, the National School Lunch Program, and the retail food distribution network. Pennsylvania will build a multi-agency Rapid Response Team (RRT) by achieving the following the program elements over the course of the performance period: RRT Development, Collaboration and RRT Assessment. __SpecificAimsTextDelimiter__ SPECIFIC AIMS Pennsylvania will build a multi-agency Rapid Response Team (RRT) by achieving the following the program elements over the course of the performance period: 1. RRT Development A project manager will be tasked with developing an implementation strategy and building-block approach to provide training and exercises, RRT response techniques, report generation, and developing improvement plans through the conduct of After-action-reports (AAR)s for RRT members. This system will incorporate lessons-learned from real events, exercises, trainings and other states' RRT best practices. 2. Collaboration Through trainings, meetings, webinars, and exercises, PDA will work closely with FDA District Offices and all members of the multi-agency RRT throughout the grant performance period. The RRT itself will be composed of thirty-five members representing Command and General Staff positions; the PA Department of Health (DoH); FDA; USDA; PDA; the PA Department of Environmental Protection (DEP); the PA State Police (PSP); the PA Emergency Management Agency (PEMA); and Food Emergency Response Network (FERN) laboratory personnel from DoH and PDA. In addition, a major component of collaboration will be the need to conduct outreach and training to the 143 local health departments who also have regulatory food inspection authority in Pennsylvania. This also includes the need for PDA to build an "emergency notification" functionality component into its nationally-recognized "PAFoodSafety" database which is utilized across food inspection jurisdictions and houses all post-harvest food establishments in Pennsylvania. This functionality would be disseminated to and utilized by all local health departments as well as PDA. 3. RRT Assessment Throughout the performance period, there will be a continual self-assessment process conducted. The self-assessment process will include the conduct of AARs and improvement plans. The improvement plans will also include evaluations of RRT performance during real events and exercises and crosswalk that performance with each of the six fundamental RRT elements and their associated metric standards. 4. RRT Incorporation The RRT capability cannot remain viable outside the cooperative agreement period without being fully integrated into the existing emergency management framework in Pennsylvania. PDA wants to ensure RRT planning and response capabilities remain viable for years beyond the performance period of the grant by migrating learned RRT concepts into PDA's ESF 11 responsibilities and the State Emergency Operations Plan (SEOP) which is maintained by PEMA. There will be a PEMA representative along with ESF 11 supporting agency representatives as members of the RRT. PEMA's primary mission is to facilitate inter-agency preparedness, response and recovery capabilities in Pennsylvania. To ensure the capability remains viable, these concepts will be driven through the development and implementation of an incorporation plan which will be designed during the 1st year by the project manager. 5. RRT Implementation and Exercise The RRT will demonstrate and test the capabilities that will be learned through the lessons learned gleaned from responses to real emergencies and exercises. The RRT will develop a "best practices manual" by understanding the five phases of RRT response (preparedness, surveillance and detection, investigation, control and mitigation, and post-response and prevention) and focusing on the four core elements (collaboration, communication, policies and procedures, and resources) which are all necessary to achieving an effective capability in each of the five phases of response. The project manager will designate an Exercise Design Team which will construct an exercise for both years two and three for all RRT members to participate in. The exercises will focus on the previously mentioned core elements necessary for a good 5-phased response and also incorporate the recommendations from previous AARs, improvement plans and the self-assessment process. 6. Documentation Lessons learned from trainings, improvement plans, self-assessments, exercises, meetings, other states RRT Best Practices Manuals will be documented into the formulation of a Pennsylvania RRT Best Practices Manual. This includes identifying preventive measures and tools and displaying these and all lessons learned in a transparent manner. PDA will also work with the FDA to identify benchmarks and develop and apply FDA metrics for RRT capabilities. ICS principles will be incorporated into RRT strategic planning and response activities. A standard ICS chart and positions will be developed by the incident commander any time there is a response and this information will be included in the best practices manual. An Incident Action Plan (IAP) will be developed for RRT responses that transcend one operational period.